CORE 2/2: INIA Stress and Chronic Alcohol Interactions: CIE-Stress Mouse Brain Activity Mapping Core (BAMC)

SUMMARY
Stressful life experiences are risk factors that play considerable roles in the development and maintenance of
alcohol (ethanol) abuse, excessive drinking, and relapse. Preclinical studies from the INIAstress Consortium that
examined chronic ethanol-stress interactions in mice have demonstrated elevations in ethanol drinking, cognitive
deficits, metaplastic adaptations, and emergence of negative affective behaviors. The INIAstress investigators
also performed mechanistic and pharmacological studies that revealed key biological targets that are responsible
for driving these aberrant behaviors in stressed, chronic intermittent ethanol (CIE) exposed mice. However, the
brain-wide neural adaptations produced by ethanol-stress interactions are unknown, and a better understanding
of the brain-wide activity patterns that underlie alcohol and stress interactions will lead to effective strategies for
treating individuals with alcohol use disorder. Recent advancements in brain-wide mapping and innovative
network neuroscience statistical approaches prompted the formation of the CIE-Stress Mouse Brain Activity
Mapping Core (BAMC). In this application, we provide preliminary data showing whole-brain light sheet imaging
of c-Fos expression and functional connectivity mapping in CIE-FSS treated mice and in mice drinking in the
intermittent access model. Thus, the primary goals of the BAMC are to 1) apply cutting-edge technology in whole-
brain light sheet imaging and expertise in network analyses to provide investigators in the INIAstress Consortium
and the scientific community with novel brain regions, circuits, and networks that drive increased drinking in mice
with a history of forced swim stress (FSS) and CIE exposure, and 2) provide brain-wide signatures of immediate
early gene (IEG) activity in response to pharmacological agents that are known to reduce the excessive drinking
phenotype in stress, ethanol dependent mice. The secondary goals of the BAMC are to 1) provide the whole-
brain mapping data to the Computational and Statistical Analysis Core (CSAC) for integration with additional
neural and behavioral data collected across all components, and 2) perform cross-INIA Consortia analyses of
whole-brain IEG expression. In Aim 1, the BAMC will generate whole-brain IEG mapping data using the standard
INIAstress Consortium model of stress-induced excessive drinking for INIAstress investigators and the scientific
community. Studies in Aim 2 will determine brain-wide IEG signatures after pharmacological treatment of drugs
that reduce drinking in the CIE-FSS model. By applying cutting-edge light sheet imaging, advanced network
analysis, and pharmacological interrogation of IEG expression across the whole mouse brain using a reliable
model that results in escalated voluntary ethanol intake in stressed, ethanol dependent mice, the BAMC will help
to generate new hypotheses and unbiased insights into systems and circuitry underlying alcohol-stress
interactions. Finally, through its interactions with the CSAC and BRAIN Initiative investigators, the Brain Activity
Mapping Core will contribute to Open Science practices that will provide the greater scientific community with
whole-brain IEG mapping data from excessively drinking mice.

Public health relevance
NARRATIVE There is a complex interaction between stressful life experiences, alcohol drinking, and the risk for developing an alcohol use disorder (AUD). The work conducted in this Core will combine the INIAstress model of stress- induced escalation of alcohol drinking in dependent mice with cutting-edge whole-brain imaging technology, advanced network analysis of activated cells, and pharmacological targeting of key systems important for stress- alcohol interactions. The overall goal is to identify novel brain regions and networks and evaluate how these networks are altered by pharmacological manipulation of critical target systems.